Nicotinic modulation of deep layer inhibitory neurons for visual cortical plasticity

Project Summary: The decline of cortical plasticity due to closure of the juvenile-specific critical period is the
key impedance of recovery from neurodevelopmental disorders and brain trauma in later life. Neuromodulatory
systems are abundant in the adult cortex and well-positioned to orchestrate experience-dependent
physiological events to prompt robust plasticity. However, an increasingly recognized complexity of
neuromodulatory circuits as well as the diversity of neuron subtypes pose a challenge to identify a specific
neuromodulatory system and their cortical target to precisely restore plasticity. The goal of this study is to
identify novel molecular and circuit targets for inducing neuromodulatory changes in the adult brain, to
reactivate juvenile-like plasticity for treating brain disorders with enduring functional impairments. Using ocular
dominance plasticity, a prevailing primary visual cortex critical period plasticity model, We will test the
hypothesis that, among various possible combinations of neuromodulatory systems, and their cortical targets,
nicotinic ACh modulation and somatostatin expressing interneurons in the deep layer of primary visual cortex
expressing specific type of nicotinic ACh sub-type as a novel combination of neurmodulatory circuit elements
to induce rapid local circuit modulation to restore juvenile-like visual cortex plasticity and recovery from
Amblyopia in adulthood. We will test this hypothesis by taking full advantage of the recently developed
genetically-engineered mouse lines to achieve sub-population and cortical-layer-specific circuit-selective
manipulation and measurement of gene expression or neural activity beyond conventional cell-type level
analysis in combination of in vivo extracellular and in vitro slice electrophysiology with optogenetics,
chemogenetics, and behavior assay. In Aim1, we will examine the contribution of specific nAChR subuniton
inducing experience-dependent rapid change of deep layer interneurons to trigger ocular dominance plasticity.
In Aim2, we will dissect the excitatory and inhibitory circuit mechanisms regulated by deep layer SST
interneurons to trigger ocular dominance plasticity. In Aim3, we will examine the extent of recovery from
Amblyopia by modulating nAChR in deep layer interneurons. Successful completion of this project will
illuminate new molecular and circuit mechanisms that gate the initial cascade triggering cortical plasticity,
which will have direct implications for Amblyopia, a condition with limited adult-applicable treatment affecting
2–5% of the human population, but also for brain injury repair, sensory recovery, and the treatment of
neurodevelopmental disorders with sensory perceptual deficits.

Public health relevance
Project Narrative: The goal of this study is to identify novel molecular and circuit targets for inducing neuromodulatory changes in the adult brain, to reactivate juvenile-like plasticity. This project will have direct implications for Amblyopia, but also for brain injury repair, sensory recovery.